Healthy Cities for Healthy Brains: Implementation of a Lead Exposure Intervention Program in Nairobi

PROJECT SUMMARY/ABSTRACT In the U.S., marked reductions in child lead exposure is noted as one of its
greatest public health accomplishments. Core features of successful programs in the U.S. include screening to
identify children with higher blood lead levels (BLLs), “healthy home” programs to identify household sources,
surveillance, and regulatory policy to remove lead from the environment. Yet lead toxicity remains a major global
public health concern, accounting for 63% of the global burden of idiopathic intellectual disability. Evidence is
clear that child blood lead levels (BLLs) once considered "safe” (< 10 ug/dL) are linked to compromised cognitive
and behavioral development. Among the one in three children with BLL exceeding current WHO guidelines (≥ 5
ug/dL), 90% reside in low and middle income countries (LMICs). Both WHO and UNICEF highlight the need for
programs to identify children with higher BLLs in LMICs, including sub-Saharan Africa (SSA), and need for
protocols to respond to cases of elevated exposure. We adapt BLL screening and “healthy home” lead prevention
program experience in the U.S. for an SSA city context - where BLL testing and follow up protocols are needed
most and can leverage the city context to build awareness - and evaluate them in foundational implementation
activities in Nairobi. Kenya has promising institutional strength in lead exposure science, and the team leverages
a 30-year research collaborative joining the University of Washington and the University of Nairobi. In Aim 1,
protocols for a Nairobi-relevant Lead Exposure Intervention Program (LEIP) are developed and refined with input
from key stakeholders, then piloted in the team’s ongoing cohort of mother-child dyads in Nairobi (age 24-36
months, N=356). Mother exit interviews inform acceptability and understanding of exposure risk surveys and risk
mitigation messaging for further refinement. In Aim 2, the refined LEIP protocol is implemented, providing blood
lead testing during routine pediatric care visits at a public Nairobi clinic (N~500 children, age 9-24 month), and
two implementation strategies are evaluated. Caregivers of children with BLL ≥5 ug/dL (N=100) will be
randomized (N = 50 each arm) to immediate tailored risk reduction messaging alone versus additional home visit
for enhanced messaging informed by an observational checklist for home risk factors. Follow-up at 3 and 9
months will include BLL rechecks and assessment of caregiver knowledge and risk reduction behaviors. Aim 3
identifies barriers to lead exposure mitigation and strategies to overcome them, using semi-structured interviews
with key persons (provider and policy level) and caregivers (individual level) involved in Aim 2. The project will
inform on minimum implementable urban SSA appropriate delivery models, based on approaches reducing lead
exposure for millions of children in high income countries for decades, and will identify contextual factors critical
for sustainable program success in future iterations. Capacity building activities and data on child BLLs and
household lead sources will fill existing critical gaps and stimulate multi-level momentum for policy changes.

Public health relevance
Project Narrative Pediatric lead poisoning is a major global health concern and the vast majority of affected children live in low and middle-income countries (LMICs), where programs to identify children at risk and intervene are lacking. This collaborative project develops a foundational lead exposure screening and follow-up program for Nairobi informed by US and Kenyan based experts. Implementation of the program in routine child care will provide insight to inform success in future iterations and other LMICs.